Role of POU4F1 in a Novel Form of Ataxia

PROJECT SUMMARY/ABSTRACT
Heterozygous, pathogenic variants in POU4F1 were recently reported by our group to cause a novel ataxia
syndrome (Webb et al., 2021). This neurological disorder is characterized by childhood onset ataxia, intention
tremor, and hypotonia, and affected individuals have global developmental delay with mildly impaired
intellectual development and speech delay or learning difficulties. POU4F1, also known as BRN3A, encodes a
class IV POU-domain containing transcription factor expressed in the developing and adult brain. Little is
known about the role POU4F1 plays in neurogenesis, neuronal differentiation, and neuronal survival in human
neurons. Therefore, we propose to use iPSC to generate cellular models of the human brain to interrogate the
consequences of POU4F1 haploinsufficiency. Our specific aims in this proposal are to 1) determine
transcriptional signatures, epigenetic status, and functional abnormalities resulting from POU4F1
haploinsufficiency in iPSC – derived neurons; 2) assess the impact of POU4F1 haploinsufficiency in a iPSC
model of the developing brain using cortical organoids; and 3) create a patient registry for POU4F1-related
ataxia and better define the clinical features of this newly identified disorder. Taken together, these studies will
uncover the pathophysiology, disease mechanism, and clinical spectrum of disease of POU4F1-related ataxia
and address fundamental questions of human neurodevelopmental biology.

Public health relevance
Project Narrative Mutations in the gene POU4F1 cause a childhood-onset ataxia, which is a condition with lack of coordination of voluntary body movements. We propose to study this disorder using cellular models of the developing human brain via the generation of 2D neuronal cultures and 3D brain organoids derived from human pluripotent stem cells with and without a POU4F1 mutation. The gene expression profiles of the wild-type and mutant cells will be compared.